Core--Cell culture

FUNCTION To provide the Program Investigators a complete cell culture and isolation delivery service that will facilitate their efforts to carry out experimental aims of individual projects. Specifically, this Core will: Achieve an economy of scale and quality assurance through centralized processing. Provide technical expertise, consultation and training in cell isolation and culture. Coordinate the design and execution of cell-based experiments.